DOUBLE LABELED IVGTT FOR ASSESSMENT OF HEPATIC GLUCOSE PRODUCTION

The purpose of this study is to determine if the time course of hepatic glucose production can be accurately predicted during an IVGTT. We have devised a method to do so employing a second tracer of glucose metabolism.